VAST Center: Viromes Across Space(s) and Time

ELSI CORE ABSTRACT
The VAST ELSI core aims to synchronize across all VAST cores to critically engage and
innovatively approach the understanding of human Viromes in research particularly in the
clinical and public health contexts. Our focus will additionally be on indigenous communities in
the US Northern Plains region, and other marginalized communities with similar concerns and
interests over big-data science and open data sharing. Our co-development of best practices
guidelines can give rise to better virome science through ethical reflection and meaningful
engagement. This ELSI research will be grounded on normative analysis of the practices and
meanings of such research and informed by empirical research that investigates factors likely to
facilitate or undermine warranted trust, contribute to promoting or undercutting equality and
respect, and enhance or minimize the potential benefits of these research. To support the
understanding of the virome, ELSI core will conduct focus groups among relevant stakeholders,
i.e., virome scientists, lay members of the public, and members of Indigenous Sovereign
Nations. An educational virome packaged will also be co-developed focus of these educational
strategies and content will be the minimization of well-known problems, e.g., bias,
underrepresentation. Altogether, an ELSI-informed (and with the Plan for Enhanced Diverse
Perspectives) a guidelines will be developed that will contribute to the development of relevant
information for consent documents, and of materials that ensure that researchers, counselors
and clinicians have the necessary tools to be aware of the ethical issues concerning viromes.